HEAT SHOCK PROTEINS

Cells under stress (heat, oxidative stress, disease, etc.) display heat shock proteins, typically at low levels, on their surfaces. We are consulting on the detection and analysis of these antigens. A manuscript is in preparation.